TOXICOLOGY STUDIES IN RATS AND DOGS ADMINISTERED AIT-102

The objective of this task order is to conduct toxicology studies in rats and dogs administered AIT-102 to support preclinical research. Any target organ toxicity seen in animals that have received AIT-102 will be identified, and the potential for toxicity reversal will be assessed.